Integrative Training Program in Cancer Biology

This proposal seeks support for launching a new “Integrative Training in Cancer Biology” (ITCB) program, which will be supervised by a select group of cancer scientists affiliated with the Massey Cancer Center (MCC) at the Virginia Commonwealth University (VCU), a 47-year National Cancer Institute-designated cancer center. The program will provide contemporary training in cancer biology to both predoctoral and postdoctoral participants. The ITCB program aims to provide a two-year training experience to three new predoctoral trainees and one postdoctoral trainee each year, 20 total trainees over the five-year project period. The main programmatic objectives of the ITCB program are to 1) match trainees with a mentorship team who will develop a tailored cancer biology-training experience and career development plan; 2) demonstrate best practices for incorporating community engagement into the design, implementation, and dissemination of research; 3) provide workshops and hands-on training with experts in cutting-edge biotechnologies; 4) offer interactive engagement through a unique cancer biology curriculum infused with the principles of community engagement; a cancer biology journal club; and an ITCB program monthly meeting to discuss research in progress, the latest advances in cancer science, and best practices for laboratory management and career development; 5) promote interdisciplinary engagement through MCC-sponsored program meetings, seminars, and retreats; 6) afford opportunities to network nationally through attendance at professional cancer research conferences; and 7) support trainees in developing extramural, peer-reviewed grant applications and submitting manuscripts based on their research. The ITCB program will be under the leadership of a Program Director and two Associate Directors who have substantial backgrounds in cancer biology and notable leadership experiences. The program will receive evaluative input from an external and an internal advisory committee, and the program faculty includes prominent MCC scientists who reside in an outstanding interdisciplinary research environment that offers remarkable opportunities for intellectual, collaborative interactions supported by extensive center-supported resources.

Public health relevance
The Massey Cancer Center (MCC) Integrative Training in Cancer Biology program aims to provide breakthrough opportunities to empower predoctoral and postdoctoral scientists to tackle the most difficult scientific challenges in addressing the nation’s cancer burden. Trainees will be oriented to the importance of integrating bidirectional community engagement in all research efforts. These predoctoral and postdoctoral scientists will also benefit from research training in the most contemporary approaches in cancer biology as well as professional career development mentoring with a highly select group of successful MCC scholars.